Post-Acute Home Health Care for Veterans: Examining Payer Source, Quality, and Outcomes

PROJECT SUMMARY/ABSTRACT
Background. Veterans are at increased risk of adverse outcomes after hospital discharge, including
rehospitalization, nursing home admission, and mortality. Post-acute skilled home health care (HHC) can
provide critical support for Veterans following a hospitalization. The services provided through HHC, including
nursing and therapies, can help Veterans meet their goals to improve function, well-being, and return to
independent living in their homes. For Medicare-eligible Veterans, skilled HHC is provided through 1) VA
purchased skilled HHC from a contracted HHC agency or 2) Medicare-funded HHC (i.e., Part A benefit,
Medicare Advantage). Preliminary work suggests that the majority (66%) of Veterans discharged home from
VA Medical Centers (VAMCs) with skilled HHC receive VA-contracted skilled HHC and the remainder receive
Medicare-funded HHC. However, funding for skilled HHC varies substantially across VAMCs, with implications
both for HHC service delivery and Veterans’ outcomes. In preliminary work, we found that 30-day readmissions
are higher among Veterans who receive VA-financed HHC compared to Medicare-financed HHC, which could
be related to HHC agency quality.
Significance/Impact. A better understanding of HHC referrals and financing, which has always been
purchased and delivered by community HHC agencies, could provide key insights for the VA given the growth
in community care for Veterans. Because community home health agencies have always provided post-acute
HHC, this context provides an ideal opportunity to examine interorganizational partnerships and Veterans’
outcomes. The proposed research will characterize post-acute HHC use, financing, and quality of care, and
how these factors are associated with outcomes for Veterans discharged from VAMCs, as well as providers’
and Veterans’ experiences of delivering and receiving post-acute HHC. Findings will inform the development of
a toolkit for VA and HHC leaders with resources to guide high-value HHC agency selection and collaboration.
The contribution of this research is significant because the results will directly inform how operational partners
choose HHC agencies to include in provider networks and develop policy for skilled HHC referrals, and will
also provide practical tools for multiple stakeholders to provide optimal HHC for Veterans.
Innovation. This is the first comprehensive study to examine VA contracting, referral practices, and financing -
including both VA and Medicare - to understand their influence on Veterans’ outcomes. A stakeholder-
engaged, complex mixed-methods study design is used to understand the mechanisms and processes that
shape the use and outcomes of post-acute HHC from multiple perspectives.
Specific Aims. 1) Identify determinants of VA vs Medicare-financed post-acute skilled HHC among community
dwelling Medicare-enrolled Veterans; 2) Understand multiple stakeholders’ perspectives on older Veterans’
use of post-acute skilled HHC and factors that influence the delivery of HHC; 3) Determine the impact of home
health agency quality and HHC payer source on differences in outcomes for older Veterans receiving post-
acute HHC.
Methodology. This proposal uses a complex mixed-methods study design with advanced statistical
techniques and comprehensive VA and Medicare administrative data, as well as a robust qualitative approach
to interview stakeholders from VAMCs, HHC agencies, Veterans, and caregivers to accomplish our aims.
Implementation/Next Steps. The culmination of findings from this work will be incorporated into a toolkit to
promote high-value HHC selection and collaboration. In addition, this work will form the foundation for a large-
scale study to develop and test implementation and effectiveness of a shared decision-making model for
Veterans and VAMC personnel to promote high-value HHC.

Public health relevance
The proposed research is relevant to VHA’s mission to “honor America’s Veterans by providing exceptional healthcare that improves their health and well-being.” Post-acute skilled home health care is a vital service for older Veterans who are discharged from VA Medical Centers to their home in need of additional nursing or therapy support. However, little is known about the decisions that influence the selection of the payer for home care services (i.e., VA versus Medicare), the quality of community home health care provided, and how these factors influence Veterans’ experiences of receiving skilled HHC and their health outcomes. Therefore, it is important to leverage both VA and Medicare data to understand HHC financing, quality, and outcomes for Veterans who receive skilled home health care, as well as the experiences of VA clinicians and staff, home health agencies, and Veteran and caregivers’ who receive this service to both inform the delivery of skilled home health care and improve Veterans’ health and well-being.